Silencer-enhancer transition dysregulates interleukin-6 in mucosal epithelial cell plasticity

PROJECT SUMMARY/ABSTRACT
Respiratory viruses, such as Influenza A virus, rhinovirus (RV), respiratory syncytial virus (RSV) and
coronavirus, trigger innate inflammation and lung tissue damage in patients of all ages, particularly premature
infants and elderly adults. During respiratory viral infection, interleukin-6 (IL-6) plays a pivotal role in promptly
and transiently activating and regulating the proper mucosal antiviral immunity to fight and clear the pathogen.
However, excessive and persistent IL-6 production may promote virus survival and exacerbation of clinical
symptoms. Therefore, the regulatory mechanisms that shape and fine-tune the precise IL-6 response to
respiratory viruses needs to be well understood. In order to gain insight into the genome-wide control of gene
transcription in mucosal epithelial antiviral response, we applied precision nuclear run-on next generation
sequencing (PRO-Seq) to human small airway epithelial cells (hSAECs) infected with RV. In the IL-6 gene
locus, we have identified an upstream cis-regulatory element (URE) that resides within an open chromatin
domain and encodes noncoding RNAs bidirectionally. Our preliminary data showed that this unannotated URE
is a dual-function regulatory element of IL-6 expression, acting as a silencer in normal airway epithelial cells
but as an enhancer in epithelial cells that undergo cellular plasticity to develop mesenchymal characteristics as
seen in chronic airway remodeling. In this R21 application, we will investigate the hypothesis that the IL-6 URE
is an epigenetic silencer of IL-6 expression in mucosal epithelial cells, and that the silencer-enhancer transition
dysregulates IL-6 expression in response to cellular plasticity. Our project seeks to understand how the
functional switch of the IL-6 URE from silencer to enhancer activity associates with IL-6 expression, either
through chromatin interactions with IL-6 promoter (chromatin looping) or via functions of its bidirectional non-
coding RNAs. We have assembled a highly skilled interdisciplinary team to dissect the contributions of our
identified IL-6 URE in two specific aims: Aim 1, the chromatin interaction between IL-6 URE and promoter
determines its function as a silencer or enhancer in different cellular contexts. Aim 2, the bidirectional non-
coding RNAs transcribed at IL-6 URE serves as docking sites to recruit epigenetic regulators that affects the
transcriptional elongation of IL-6. We are the first to identify IL-6 URE and its derived noncoding RNAs that will
advance us to understand how dynamic interactions between cis-regulatory elements facilitate precise gene
regulatory response to epithelial cell plasticity. Our final goal is to offer novel translational targets that
selectively alter IL-6 expression in certain cell settings while not in others, therefore significantly reducing side
effects for therapeutics of IL-6 associated clinical disorders.

Public health relevance
PROJECT NARRATIVE This interdisciplinary project aims to unravel the mechanisms of protective mucosal innate immunity activated during respiratory virus infections. The question we address is how the inflammatory IL-6 response is poised for rapid activation by gene silencer and its noncoding RNAs when viruses invade the airway, and how this regulatory process is disrupted in the context of chronic airway remodeling observed in lung diseases like allergic asthma.